Harnessing multimodal data to enhance machine learning of children’s vocalizations

Project Summary This Administrative Supplement proposes implementation of a multimodal data pipeline to support machine learning of child language production in complex naturalistic environments. The Supplement builds on the parent R01 (DC018542) that gathers objective, longitudinal data to capture the vocal interactions of children with hearing loss (HL). Even with cochlear implantation, HL is a life-altering condition with high social costs. Inclusion of children with HL and typically hearing (TH) peers in preschool classrooms is a national standard, but it is not clear how early vocal interaction contributes to the language development of children with HL and their TH peers. The parent R01 employs computational models of child location and orientation to indicate when children are in social contact with their peers and teachers. An additional strategy for pursuing the broad goals of the R01— identifying interactive contexts in which children produce phonemically complex vocalizations and interactive speech—is machine learning. Machine learning algorithms can determine the contextual, individual, and interactive factors that predict children’s vocalizations and vocal interactions. However, the parent R01 does not propose machine learning, nor are data disseminated in a format designed to facilitate machine learning. To facilitate machine learning in the classroom, a rigorous diarization process is required to determine speaker identity, which is operationalized as the likelihood that each vocalization was spoken by a given child or teacher. We will integrate audio processing of each target child and teacher’s first-person audio recording with processing of their interactive partners’ recordings. The influence of partner recordings will be determined by their physical distance and orientation relative to the target. This will yield a weighted speaker identification score for each vocalization. For 25% of the sample, the algorithmic score will be compared to speaker identification provided by trained coders to quantify intersystem reliability. Processed datasets will include 7,160 hours of multimodal recordings of child and teacher movement in classrooms synchronized with continuously recorded, child- and teacher-specific (first-person) audio recordings. De-identified output data will characterize vocalizations with respect to algorithmically computed speaker identification probabilities, coder-identified speaker identity (25% of sample), phonemic complexity and audio characteristics (e.g., fundamental frequency), as well as the position and relative orientation of all individuals in the classroom, and child demographics (including characterizations of HL). Over the course of the supplement, output data, Python processing code, and metadata descriptions of the processing pipeline will be disseminated in dedicated distribution portals including Github, Kaggle, and the UCI repository. Recordings will be released to certified investigators via NIH-funded repositories such as Databrary and Homebank.

Public health relevance
Overview. The current Administrative Supplement proposes implementation of a multimodal data processing pipeline to produce data ready for machine learning (ML). The Supplement is a response to NOT-OD-21-094 which calls for sharing “data generated through NIH-funded research” in ML-ready form. Disseminated data will facilitate the ML detection of child vocalizations and the prediction of child vocalizations in a complex natural context. The Supplement builds on parent grant (R01DC018542), which gathers intensive longitudinal data to capture the vocal interactions of children with hearing loss (HL) in preschool classrooms. The proposed supplement pipeline will integrate multi-source, multimodal objective recordings to computationally identify when children are vocalizing, compare those results to trained coders, and release all data, code, and metadata to enhance machine learning of child speech. Parent R01 premise. The parent R01 uses objectively measured, longitudinal data to capture the vocal interactions of children with hearing loss (HL) in order to understand everyday factors that facilitate their language development. HL, including deafness, is associated with delays and difficulties in social and language development. Even with cochlear implantation (CI), HL is a life-altering condition with high social costs. Inclusion of children with HL and typically hearing (TH) peers in preschool classrooms is a national standard, but it is not clear how day-to-day interactions contribute to the language development of these children. The R01 premise, supported by the team's ongoing research data, holds that vocal interactions with peers and teachers in inclusive classrooms positively influence the language development of both children with and without HL (Fasano et al., 2021; Perry et al., 2019; Perry et al., 2018). Parent R01 objective data collection. Temporally intensive, objective measurements of child and teacher movement in classrooms are synchronized with automated analysis of continuously recorded, child-specific audio recordings. First-person audio and radio frequency identification (RFID) of location and orientation occur twice a month. In the classroom, children are outfitted with specially-designed lightweight vests (and teachers are outfitted with fanny packs) containing two Ubisense RFID tags (left and right, to detect both location and orientation) and a LENA first person audio recorder when they arrive at preschool. Using multiple sensors (radio cells) linked by a timing cable, the RFID Ubisense system can track up to 40 participants 4 times per second to an accuracy of 15cm in classrooms of up to 8m * 8m * 2.5m dimensions (Wo?niak et al., 2013). Sensors track active tags worn by children (and teachers) in XYZ space by means of triangulation (angle of arrival, AoA) and time differences in arrival (TDoA). As part of Supplement preprocessing, a Multiplicative Extended Kalman Filter (MEKF) based filter (Sabatini, 2006) will be applied to de-noise the raw child and teacher position and orientation data (Crassidis et al., 2007). R01 overall goal. The overall goal of both the R01 and the Supplement involves identifying contexts in which children produce vocalizations, particularly phonemically complex vocalizations. The premise is that children's vocalizations create opportunities for both direct feedback (producing and hearing one's vocalizations) as well as interactive feedback from peers and teachers (Fusaroli et al., 2019; Hirsh- Pasek et al., 2015; Ribot et al., 2018). In support of this premise, the team's ongoing research indicates that both the overall quantity (rate per minute) of children's vocalizations, and the phonemic complexity of those vocalizations (the mean number of unique speech sounds per vocalization) are associated with children's assessed receptive and expressive language abilities (Altman et al., 2020; Fasano et al., 2021; Perry et al., 2019; Perry et al., 2018). R01 approach. The parent R01 does not propose or utilize machine learning. Instead, the R01 tests a priori hypotheses to predict child vocalizations. Specifically, the parent R01 investigates whether exposure to peer and teacher vocalizations during periods of social contact longitudinally predicts higher levels of vocalizations to those partners. Exposure to more responsive partner vocalizations and more phonemically complex vocalizations is hypothesized to yield higher rates of more phonemically complex child vocalizations. Computational modeling of children's physical location and interpersonal orientation within classrooms indicate when children are in social contact with peers and teachers. Although social contact is computed from observed data in the parent R01, it is derived exclusively from physical proximity and orientation. The empirical relationship between social proximity, social orientation, and vocalization production and vocal interactions is not known. Supplement-enabled approach (machine learning). Machine learning is a complementary approach to the broader R01 goal of identifying factors that foster language production. Machine learning offers data-driven opportunities to discover both expected and unexpected associations that support child vocalizations and language development. Machine learning refers to algorithms that iteratively represent data in a more abstract form to identify patterns of interest. These algorithms frequently capitalize on nonlinear associations between large sets of predictor variables to learn patterns in real- world data (LeCun et al., 2015). Value of machine learning of Supplement data. The Supplement will pave the way for the application of supervised machine learning approaches to predict the conditions when children speak and the complexity of the speech they produce. Moreover, machine learning can be used to predict children's vocal interactions with both children and teachers, which appear to facilitate language development (Perry et al., 2018; Romeo et al., 2018; Weisleder & Fernald, 2013). Machine learning can discover temporal, contextual, and individual interactive factors predicting vocalizations and vocal interactions. Temporal and dynamic factors. Temporal features of a child's vocalization stream are likely to condition the likelihood of subsequent vocalizing; that is, children frequently generate successive vocalizations in close temporal proximity to one another (Abney et al., 2017). Likewise, the velocity of children's movement (and their relative velocity with respect to partners) are dynamic features that may be associated with the likelihood of vocalizations. Machine learning allows for the integration of such temporal and dynamic features into detection and prediction algorithms. Contextual and group factors. Contextual factors include classroom activities (e.g., circle time and free play) that are annotated as part of the parent R01. A potential machine learning goal is identification of classroom activities from the movement and orientation of children and teachers in the class (activity recognition). Classroom activities, in turn, may condition nonlinear associations between predictors. When children are shoulder-to-shoulder (rather than face-to-face) they may be likely to respond to one another's vocalizations, but only when their physical movement is diminished such as when they are sitting next to one another during small group activities. Likewise, the parent R01 is limited to analyzing group interactions as a series of dyadic interactions while machine learning approaches can leverage nonlinear changes in vocalization propensity associated with group size. Individual factors. Children with hearing loss (HL) exhibit delayed and variable language development, which is associated with functional outcomes (Geers et al., 2016; Koehlinger et al., 2013; Spencer et al., 2003). Importantly, children with HL are responsive to enriched language environments (Cruz et al., 2013). The parent R01 investigates whether hearing loss (HL vs TH) and hearing age influence associations between speech in social contact and speech production using planned contrasts in multivariate statistical models. By contrast, machine learning approaches have the potential to identify both similarities and differences in the contextual features that support the vocalizations of children with HL and typical hearing. Children with HL, for example, may benefit disproportionately from vocalizations from partners who are directly in front of them. Supplement datasets. The Supplement will process two multimodal datasets (first-person audio and synchronized RFID position/orientation information) from a multiethnic sample of children with hearing loss (HL) and typical hearing (TH). The datasets involve multiple (monthly and bimonthly, respectively) multi-hour recordings totaling 7,160 hours. Preliminary Dataset: 716 multimodal recordings of 82 children (44 HL and 38 TH) and 16 teachers comprising 2,360 hours of data collected prior to and in the first months of the parent R01. Supplement Dataset. 960 multimodal recordings of 40 children (24 HL and 16 TH) and 8 teachers comprising 4,800 hours of data to be gathered during the Supplement period (10/1/21 - 9/30/22). Finally, to enhance impact, the pipeline will be utilized after the Supplement period over the remainder of the Parent R01 to include an additional 85 children (31 HL, 54 TH) and 12 teachers, producing an additional 3,840 multimodal recordings with a combined duration of 19,200 hours. The Supplement's sequential processing and release of multiple datasets will allow for tests of the generalizability of machine learning models. Supplement team expertise. The collaborative project team possesses ample expertise to carry out supplement activities. MPI Messinger has employed computer vision of facial movement (Martin et al., 2018; Messinger et al., 2009; Messinger et al., 2012), signal processing of vocalizations (Esposito et al., 2014), and automated tracking of children's classroom movement (Messinger et al., 2019) in over a dozen years of funded research. MPI Perry is a language development researcher who employs first- person audio recordings to study children's language development in children's classroom environments (Altman et al., 2020; Perry et al., 2019; Perry et al., 2018). Consultant Narayan is an expert on audio processing and multimodal data integration whose extensive research portfolio has generated a broad array of publications, tools, data, patents and system prototypes (Lahiri et al., 2020; Pal et al., 2021). Supplement approach. To facilitate machine learning in the classroom, a rigorous diarization process is required to determine speaker identity. Determining speaker identity in naturalistic environments remains a challenge, particularly when some or all speakers are children. We operationalize speaker identity as the likelihood that each vocalization was articulated by a given child or teacher. In the Parent R01, speaker identity is determined by LENA diarization of the target child's first person audio recording. In the Supplement, speaker identity is determined by diarization of the target child's first person audio recording in conjunction with diarization of the first person audio recording of the target child's partners (peers and teachers). The relative weight accorded to the diarizations of the target child's partners is determined by their distance from and orientation to the target child. The distance between the target child and their partners, as well as their relative orientation, is provided by synchronized RFID position and orientation information of all children and teachers in the classroom. Speaker identification based on interpersonal distance and orientation. We will integrate audio diarization of each target child recording with diarization of their respective interactive partners as determined by the physical distance and relative orientation of the target and partner. Children serve iteratively as targets and peers in data processing. To determine the weighting function of a partner we calculate their distance to the target and the target and partner interpersonal orientations. An exponential function decreases weight (?) proportional to the square of the distance between the target child and partner (peer or teacher) and their interpersonal angular difference from face-to-face contact as follows: ???, ??, ??? ? ???????/2??? ? ???/2??? ? ???/2???? , (1) where the radius ? ? ???? ? ???? ? ??? ? ???? represents the distance between pairs of individuals, and θ1 and θ2 are their respective orientations toward one another (interpersonal orientations). A distance of 1 meters and an interpersonal orientation of 15 degree are used as arbitrary scaling factors (σr = 2m and σθ =15o). Thus the weight (influence) of peer recordings rises as the distance between the peer and the target decreases, and as their orientation becomes more face-to-face (see Figure 1). This procedure yields weighted speaker identification likelihoods for each vocalization. Both likelihood scores and a winner-takes-all vocalizer will be reported continuously in time for each audio recording. Harnessing audio processing advances. The parent R01 uses LENA SP/Hub Version 3.4.0 proprietary software, which diarizes vocalizations with Gaussian Mixture Models (GMM) and Hidden Markov Model (HMM) trained on English input (Gilkerson & Richards, 2009; Xu et al., 2009). GMM and HMM are rarely employed in modern audio speech processing, however, having been supplanted by deep neural networks (DNNs) that recursively represent the raw audio signal at increasing levels of abstraction to identify speech and speakers (Pal et al., 2021). In the Supplement, audio recordings will be diarized using ALICE, an open-source, multi-language toolkit trained on multiple, first-person audio recording corpora from diverse linguistic and socioeconomic contexts (Räsänen et al., 2020). ALICE uses a series of DNNs (recurrent neural networks and a convolutional neural network) to identify and categorize (segment) speech as target child vocalizations, peer vocalizations, and adult vocalizations (Lavechin et al., 2020). In addition, we will characterize first person audio streams with mel-frequency cepstral coefficients (MFCCs) in Python and estimate the phonemic complexity (consonant and vowel sounds) of identified vocalizations using CMUSphinx (Walker et al., 2004) to enhance the value of disseminated data for machine learning research. Additional machine learning applications. For machine learning researchers investigating speech diarization the release of annotated audio recordings will be a major resource. The proposed multimethod, multimodal estimation of speaker identity, together with source audio (and movement) files, will facilitate machine learning research focused on improving speech detection and speaker identification (diarization) algorithms. The DNN diarization provided by ALICE will serve as baseline levels of speech detection and speaker identification while the provision of human reliability coding (annotations) will serve as a reliability benchmark. Reliability coding. To benchmark intersystem reliability, 25% of recordings will be annotated by one of 15 undergraduate coders trained to reliability—and regularly assessed for drift—by the project Research Associate. Coders will be randomly assigned 25% of each participant's first person audio recordings, which will allow them to become familiar with that speaker's vocalizations. Using ELAN (ELAN, 2019), coders will identify vocalizations and designate the speaker as Target, Peer, or Teacher. The team has experience with reliability coding in ELAN and preliminary data suggest the reliability of coders with LENA diarization (e.g., Cohen's Kappa = .77). Reliability of both speech detection and speaker designation between ALICE and trained coders will be assessed via Kappa, Diarization Error Rate, and Jaccard Error Rate (Fiscus et al., 2006; Ryant et al., 2019). Diversity, privacy, and consent. The makeup and demographic balance of the proposed datasets can contribute to reducing algorithmic bias. Preliminary and initial data indicate that the child and the teacher sample will be ethnically (50% Hispanic and 50% not Hispanic) and racially (23% Black [Caribbean and African American], 74% White, and 3% Asian) diverse. The child sex distribution is approximately 58% male while teachers are 90% female. In addition, the team is highly sensitive to issues of confidentiality. De-identified databases will be made publicly available; however, audio recordings will be made available only to certified investigators on portals employing 'walled garden' procedures such as Databrary. All participating parents explicitly consent to these procedures. Dissemination. Although the parent R01 is not designed to disseminate data in a ML-ready format, this is a central goal of the Supplement. The Supplement pipeline for producing the ML-ready de-identified dataset will be developed in Python, and include a loader to facilitate feeding data to deep learning frameworks, including PyTorch and Tensorflow. De-identified data will characterize vocalizations with respect to onsets and offsets, algorithmically computed speaker identification probabilities (and, for 25% of recordings, human coded speaker identification), MFCCs (including fundamental frequency, and intensity), phonemic complexity, the position and relative orientation of all individuals in the classroom, classroom activity codes (e.g., free play), and child demographics (including characterizations of HL). Python code, de-identified data in .csv format, and metadata descriptions of the data and processing pipeline will be disseminated via repositories including Github.com, Kaggle.com, the UCI Repository (archive.ics.uci.edu), and the Open Science Framework (osf.io). Synchronized source audio recordings (.wav files) along with de-identified data and metadata will be disseminated via NIH/NSF-funded repositories including Databrary.org and Homebank (homebank.talkbank.org).